Using proteogenomics to assess the functional impact of alternative splicing events in glioblastoma

PROJECT ABSTRACT
Glioblastoma (GBM) is the most malignant type of brain tumor, with a median survival time of 15 months.
Despite advances in cancer survival for many malignancies, GBM survival rates still remain low and have not
significantly changed over the last 30 years, emphasizing the urgent need for new treatment options. One of
the common hallmarks of cancer is splicing perturbations and alternatively spliced genes are an interesting
new source for potential diagnostic biomarkers and therapeutic targets. Current methodologies to characterize
splicing in tumors using mRNA sequencing can only indicate that alternative exons are transcribed, but
additional validation is needed to verify that these spliceforms produce functional proteins. Our preliminary
results comparing paired tumor/normal samples indicate that alternative splicing in GBM affects many more
genes than previously expected, both at the transcript and protein levels. Based on these data, we hypothesize
that a set of alternatively spliced genes are involved in tumor initiation and GBM pathogenesis. In this proposal,
we will use a combination of precision medicine approaches to detect and quantify tumor-specific alternative
splicing events in GBMs. We will verify that these events produce distinct proteoforms using splicing-aware
proteogenomics experiments. Finally, we will functionally characterize differentially expressed splice isoform
candidates for their effects on growth, apoptosis, and invasion in patient-derived glioma stem cells. If
successful, this work will lead to new understanding of the biological impact of novel GBM proteoforms, and
potentially lead to novel approaches to treatment of GBM based on unique tumor antigens and molecular
pathways.

Public health relevance
PROPOSAL NARRATIVE Glioblastoma (GBM) is the most aggressive type of glioma, characterized by fast growth and poor prognosis, with an average survival of 15 months. Here we will apply a systematic molecular analysis to identify alternatively spliced genes in GBMs and then validate the biological function of those splice forms in patient- derived glioma stem cells. Our main goal is to identify putative alternative splicing genes as therapeutic targets for future studies in personalized medicine.